CHARMM MAINTENANCE ACCOUNT

This subproject is one of many research subprojects utilizing the resources provided by a Center grant funded by NIH/NCRR. The subproject and investigator (PI) may have received primary funding from another NIH source, and thus could be represented in other CRISP entries. The institution listed is for the Center, which is not necessarily the institution for the investigator. Testing new features of CHARMM that will enable increased performance and scalability. Test runs will be of short duration but may need many processors.